Defining the Unique Properties of the Distinct Signaling Machinery Used by the TCR

OVERALL PROJECT SUMMARY/ABSTRACT
This application is a revision of a renewal of an ongoing Program Project in which five investigators with
different but complementary expertise have worked together for 10 years to understand poorly characterized
but fundamentally important aspects of TCR signaling. Synergy resulting from interactions and collaborations
has yielded impressive progress. The Program benefitted enormously from the complementary expertise,
skills and approaches by the 5 investigators from structural biology, proteomics, immunology, biophysics,
imaging and computational biology. In addition to the synergy created by the distinct expertise of each of the
investigators and the progress we have made over the previous 10 years, we also take advantage of a
Proteomics Core that has extended our strategies and analytic skills in proteomics. Our collaborative studies
have resulted in considerable progress and productivity. In this revision, a major change that we have made is
an increase in the number of projects from 2 to 4 in order to allow for more fully developed aims and
approaches to answer the following unanswered questions: 1) What are the unique features of the kinases
employed by TCR that have been optimized for regulating critical downstream tyrosine phosphorylation and for
unique characteristics involved in ligand discrimination? 2) What are the properties of the circuitry that allow
for discrimination of self-pMHC from agonist-pMHC recognition to establish a stable homeostatic state versus a
robust cellular response? 3) How is the adaptor LAT condensation regulated and serve to coordinate and
amplify the diverse signaling events associated with a robust cellular response? 4) How does the TCR
signaling network regulate Ras guanine nucleotide exchange factors (GEFs) with downstream, canonical and
non-canonical effector kinase signals in a properly regulated and faithful manner to incoming TCR signals? To
answer these questions, a new Project is now incorporated into this proposal to address each of these issues.
Our overall goal then is to capitalize on our current progress and leverage our distinct knowledge and skills
related to TCR signaling to more completely understand the distinct features of the molecules, the circuitry and
the regulation of TCR signaling that enables and ensures appropriate biological responses.

Public health relevance
OVERALL PROJECT SUMMARY In this Program Project renewal, we bring together investigators with very different expertise and approaches from structural biology, proteomics, immunology, biophysics and computational biology to understand T cell antigen receptor (TCR) signaling. We will study the distinct features of the T cell-expressed tyrosine kinase enzymes that make these most suitable for TCR signaling, how the biochemical features and assembly of particular molecules are used to amplify signals, how distinct signaling pathways coordinate different cellular responses and how signaling circuitry generated enables the T cell to discriminate and respond to signals generated from self-antigens versus pathogen or tumor antigens.